Cyclic endocrine neuromodulation shapes sensory and spatial representations

Project Summary
Ovarian hormones such as estradiol and progesterone are increasingly implicated in the sex-specific etiology
of neurological disorders. Conditions like Alzheimer’s disease, for instance, are more than twice as likely to
arise in women compared to men, with accumulating evidence pointing to a depletion of circulating hormones
across the menopause transition as a critical risk factor. However, the mechanisms underlying steroid hormone
modulation of neural circuits remain unclear. The estrous cycle offers an ideal window into the sex-dependent
mechanisms underlying neurological disorders, as structural and functional plasticity are tightly coupled with
naturally cycling levels of steroid hormones. In this project, we will use 2-photon microscopy, viral gene editing,
and computational analysis of neural and behavioral data to assess the effect of the estrous cycle on sensory
and spatial representations. Our preliminary data indicate that pyramidal neurons in hippocampus exhibit
elevated dendritic spine density and greater place field remapping during high-estradiol stages of the estrous
cycle. In the F99 phase of this proposal I will establish the molecular mechanisms underlying hormonal
changes in spatial coding by using CRISPR/Cas9 to target specific receptors. In the K00 phase I will elucidate
how hippocampal circuits are modulated by sensory perception across the estrous cycle, and how this
influences ethological behaviors. To accomplish this, I will first track dendritic spine turnover as a function of
estrous cycle stage and identify the specific endocrine receptors responsible for driving estrous-dependent
changes in spine turnover (Aim 1.1). Using two-photon microscopy, I will measure dendritic spine turnover in
hippocampal region CA1 and use viral gene editing to knock down targeted hormone receptors in a subset of
CA1 neurons. Dendritic spine turnover will be evaluated between wild-type and knockdown cells. Second, I will
record the functional responses of place cells across the estrous cycle as they remap between environments
(Aim 1.2). Targeted receptor knockdowns will be used to determine the mechanistic role of endocrine
receptors in shaping the flexibility of spatial representations. In the K00 phase, I will take the skills and insights
gained from the F99 phase and use them to investigate the role of the estrous cycle in modulating ethological
behavior (Aim 2). I will leverage unsupervised machine learning to evaluate a caching behavior dependent on
the hippocampal-olfactory circuit, while recording the activity of olfactory bulb neurons that project to CA1 by
way of entorhinal cortex. Chemogenetic silencing of these projections will be used to uncover the mechanism
underlying behavioral and circuit-level changes across the estrous cycle. Ultimately, the proposed work will
represent a significant advance in our understanding of the modulatory role of steroid hormones in cognition,
and facilitate the development of individualized sex-dependent treatments for neurological disorders.

Public health relevance
Project Narrative Mammalian cognition is fundamentally shaped by steroid hormones, which in turn have major effects on neurological disorders such as epilepsy, schizophrenia, and Alzheimer’s disease, the underlying mechanisms of which remain poorly understood. To address the mechanistic action of hormones in the brain, we will use novel multiphoton imaging, viral gene editing, and ethological behavioral analysis to determine how cyclic endocrine fluctuations across the estrous cycle modulate hippocampal and olfactory plasticity. These results will provide critical insight into the role of steroid hormones in memory function and improve our understanding of sex-specific contributions to neurological disease.